Modulating Ferroptosis in Fuchs Endothelial Corneal Dystrophy

PROJECT SUMMARY/ABSTRACT
Fuchs endothelial corneal dystrophy (FECD) affects 6.1 million Americans over 40 years of age, is the leading
indication for corneal transplant surgery, and although it can be diagnosed early it requires corneal
transplantation because no medical therapy can prevent its progression. Genetic factors, abnormal cell-matrix
interactions, and oxidative stress induced by ultraviolet light-A (UVA) all contribute to FECD, but the precise
mechanisms inciting cell death remain poorly understood. We present novel and compelling evidence that
ferroptosis, a nonapoptotic oxidative cell death resulting from iron-mediated lipid peroxidation, is a key driver of
corneal endothelial cell (CEC) death in FECD. Specifically, increased reactive iron (Fe2+) concentrations, lipid
peroxidation, and expression of transferrin receptor (TFR1, a ferroptosis-specific marker) occur in corneal
endothelial tissue from FECD patients. These data are foundational and guide us to further investigate drivers
of ferroptosis in FECD. Pathological extracellular matrix features in FECD (e.g., guttae) are recognized risk
factors associated with premature CEC death in FECD. Exciting preliminary data indicate that FECD patients
have increased TFR1 expression surrounding guttae compared with adjacent cells, which compels us to study
the role of guttae in driving ferroptosis. Additionally, UVA exposure is a risk factor that drives FECD progression
and triggers ferroptosis in other exposed tissues (e.g., skin). Exciting preliminary data demonstrate that UVA
increases Fe2+ concentrations, which leads directly to Fenton reactions and oxidative damage in lipid membranes
with subsequent ferroptosis-induced cell death in FECD. Our overall goal is to develop a preventive medical
therapy (e.g., eye drops) that preserves corneal function, protects against vision loss, and increases quality of
life without surgery for FECD patients. To achieve this, we will target iron-mediated lipid peroxidation that is
involved in FECD progression. Our team is well positioned to conduct this research due to our expertise in
ferroptosis and animal models of FECD and phamacoengineering. The overall objectives of the proposed
research are to investigate how guttae and UVA drive ferroptosis in FECD and develop anti-ferroptosis drug
therapy using in vitro and in vivo FECD models. Our central hypothesis is that FECD genetics predispose CECs
to ferroptosis, and that guttae eruption through the CEC monolayer and UVA exposure both drive aberrant
reactive iron to accumulate in cells and cause ferroptosis. Guided by strong preliminary data, the hypothesis will
be tested through the following specific aims: 1) Define the interplay between guttae and ferroptosis in FECD; 2)
Determine how UVA mediates ferroptosis in FECD; and 3) Modulate ferroptosis to mitigate cell loss in FECD.
The approach is innovative in that we will utilize well-characterized human tissues and primary cells from FECD
patients, multiple animal models of FECD, and state-of-the-art technical assays. The proposed research is
significant because it will clarify the mechanism of how genetic and environmental risks lead to premature cell
death through ferroptosis in FECD, and advance targeted drug therapy to prevent or delay its progression.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because in spite of early detection, Fuchs endothelial corneal dystrophy (FECD) inevitably progresses to vision loss requiring corneal transplantation. The proposed investigation of the molecular mechanisms driving FECD progression would close the knowledge gap of how genetic and environmental risks lead to premature cell death, develop a mechanism-based framework for understanding disease progression, and improve public health by advancing targeted drug therapy to delay disease progression and prevent the need for surgery. Such alternative treatments are critical to develop given the high prevalence of FECD (more than 4% of the U.S. population is affected), the high frequency of requiring corneal transplant surgery (FECD is the top indication for corneal transplantation), and the worldwide shortage of donor corneal tissue (only 1 donor cornea is available for every 70 needed).